CD5-deleted chimeric antigen receptor cells (Senza5 CART5) to enhance immunotherapy against T cell non-Hodgkin lymphoma (NHL): a first-in-human phase I clinical trial

PROJECT SUMMARY
The long-term goal of this research is to change the prognosis of relapsed or refractory (r/r) T-cell Non-Hodgkin
Lymphoma (T-NHL) using next-generation chimeric antigen receptor T-cell (CART) immunotherapy. CART
therapy has led to remarkable clinical outcomes in B-cell malignancies, but the needle has not moved for most
other cancers. Relapsed or refractory T-NHL are considered mostly incurable with available therapies and
present a particular challenge for antigen-specific T-cell immunotherapy since normal and malignant T cells
largely express the same surface antigens. Our group developed a novel approach to circumvent CART fratricide
by deleting the pan T-cell antigen CD5 in T cells that are transduced to express an anti-CD5 CAR. Of note, our
work demonstrated that the deletion of CD5 also enhances T-cell effector function by enhancing CAR signaling.
The present project seeks to test this discovery in a first-in-human clinical trial to evaluate the feasibility, toxicity,
and efficacy of CD5 deleted anti-CD5 chimeric antigen receptor CART for T-NHL. The central hypothesis of this
grant is that CD5 deleted anti-CD5 CAR T cell immunotherapy is safe and can lead to potent and long-term
clinical responses against T-cell lymphomas. Moreover, this research will explore whether the CD5 KO
untransduced (CAR-negative) T cells from the CD5 KO CART5 product can provide short-term T-cell immunity
in case of CART5 toxicity against the normal T cells that express CD5. The feasibility of this proposal is
underpinned by our preliminary results and our Institution’s extensive expertise in translating CART therapies.
A dedicated study team was formed with experts with complementary expertise, including the proposal’s principal
investigator (Dr. Barta, clinical lead), co-PI (Dr. Ruella, correlative lead), biostatistician (Dr. Hwang), clinical
research staff, and laboratory personnel to ensure the timely success of this proposal. Financial support has
been secured from viTToria biotherapeutics, Inc, who serves trial sponsor. The central hypothesis will be tested
by pursuing two specific aims. In Aim#1, the phase I clinical trial will be performed to evaluate feasibility, toxicity,
and efficacy of autologous CD5-deleted anti-CD5 CAR T-cells for r/r non-leukemic T-NHL. The trial will utilize an
Bayesian optimal interval design to establish the recommended phase II dose. In Aim#2, two working hypotheses
will be tested using clinical samples obtained from Aim#1: i. CD5-deleted CART5 can potently expand and
infiltrate tumors; and ii. CD5-deleted untransduced cells presented in the product can persist in the blood, limiting
T-cell aplasia. Several laboratory techniques will be used for the correlative studies, including will flow cytometry,
single-cell transcriptomics, cytokine profile and digital spatial profiling to study the T-cell dynamics and function
in the blood and tumors. The proposed research is highly relevant to public health because patients with r/r T-
NHL have no available cures with standard non-cellular therapies. This study will significantly impact the field of
cancer immunotherapies by developing a novel potent anti-T-cell lymphoma immunotherapy and such address
an unmet need in a rare disease.

Public health relevance
PROJECT NARRATIVE This proposal seeks to test for the first time in humans, a novel CD5 deleted anti-CD5 chimeric antigen receptor T cell (CART) product for patients with relapsed or refractory T-cell lymphomas. The proposed research is highly relevant to public health because patients with relapsed or refractory T-cell lymphoma have no available cures. The project is relevant to those parts of the FDA’s mission that pertain to the acceleration of innovative therapies, the advancement of scientific knowledge and to help all people live longer healthier lives.